Enhancing triple negative breast cancer response to immune checkpoint inhibitor therapy via targeted therapies

Project Summary
Triple negative breast cancer (TNBC) is a subtype of breast cancer that is aggressive and difficult to treat, with
limited treatment options beyond traditional chemotherapy. Given the recent approval of treatment of TNBC with
the immune checkpoint inhibitors, anti-PD1 and anti-PDL1, combined with nab-paclitaxel, we are evaluating
strategies that prime tumors to be more responsive to immune checkpoint inhibitors (ICI). Overactivation of the
PI3K/AKT pathway is implicated in about 23.7% of TNBC tumors and is known to contribute to the maintenance
of an immunosuppressive tumor immune microenvironment (TIME). This proposal will investigate the hypothesis
that pan-AKT inhibition (AKTi) will enhance the efficacy of treatment with existing immune checkpoint inhibitors
in some but not all preclinical models of TNBC, including mouse models and patient-derived organoid models.
Experiments proposed in aim 1 will investigate how pan-AKTi affects the TIME when used in conjunction with
anti-PD-1, anti-CTLA4, and a combination of anti-PD-1 + anti-CTLA4 (ICI). In vivo murine studies will be
performed in AKTi responsive PYMT tumors and AKTi non-responsive EO771, 4T1, and 6DT1 tumors. Multi-
color flow cytometry will allow detailed immunophenotyping of tumor and peripheral sites such as blood,lymph
node, and spleen. Additionally, In vitro studies with T-cells will explore the mechanisms through which AKTi may
enhance ICI efficacy as well as mechanisms of resistance to AKTi. In aim 2, a high throughput screen will be
used to identify potential candidate drugs that enhance T cell-mediated tumor cell killing and therefore have the
potential to enhance the efficacy of existing immune checkpoint inhibitors. A number of pan-AKT inhibitors as
well as candidate drugs identified in the screen will be evaluated in patient-derived organoid models established
from TNBC patients undergoing surgical resection. We will look for synergism between AKTi with immune
checkpoint inhibition, evaluating direct AKTi-mediated tumor cell killing and immune-mediated tumor cell killing.
These studies will enhance our understanding of mechanisms of response and resistance to AKTi in TNBC and
the role of AKT inhibition in priming the tumor immune environment to enhance response to immune checkpoint
inhibitors. We will identify alternative inhibitors that enhance TNBC response to ICI for those tumors that do not
respond to AKTi. By examining the response of these therapies in organoid models of human TNBC, we will be
able to predict parameters of response to therapy in a heterogenous population of TNBC patients.

Public health relevance
Project Narrative The AKT pathway is often aberrantly activated in breast cancer and acts to promote both tumor growth and the maintenance of an immunosuppressive tumor microenvironment. The proposed studies will investigate the potential of pan-AKT inhibition to enhance the efficacy of immunotherapy strategies in mouse models of triple negative breast cancer and patient-derived organoid models. High throughput screening with a tumor-immune cell co-culture system will be used to identify additional targeted strategies, beyond AKT inhibition, that enhance T-cell mediated tumor cell killing and have the potential to synergize with immune checkpoint inhibition.